Regulatory control of inflammatory cytokine production by a linear ubiquitin-binding protein

PROJECT SUMMARY/ABSTRACT
This proposal outlines a five-year plan for the PI, Dr. Alexander Gitlin, to prepare him for an independent
academic career as a physician-scientist. Dr. Gitlin received his M.D./Ph.D. degrees from the Weill
Cornell/Rockefeller/Sloan-Kettering Tri-Institutional M.D.-Ph.D. program and is currently completing residency in
Clinical Pathology at Stanford Hospital and Clinics. During residency, Dr. Gitlin developed a jointly mentored
research program, co-advised by Drs. Bali Pulendran (Stanford University) and Vishva Dixit (Genentech, Inc.).
Drs. Pulendran and Dixit are longtime colleagues and collaborators with highly complementary expertise. Dr.
Pulendran is an expert in toll-like receptors, innate immunity, and dendritic cells; Dr. Dixit is an expert on
inflammatory signaling, cell death, and ubiquitin biology. Both Drs. Pulendran and Dixit have served as mentors
to numerous trainees, many of whom have become leading investigators in academia or industry. This joint
mentorship program provides Dr. Gitlin with full access to the combined resources and expertise present at two
neighboring, world-class research institutions, Stanford University and Genentech, which will provide
outstanding environments for Dr. Gitlin to develop his own independent scientific career. In addition, Dr. Gitlin
has assembled a K08 advisory committee composed of senior investigators whose scientific expertise and
mentorship will greatly aid Dr. Gitlin’s career development. They include Drs. Stephen Galli, Denise Monack,
Scott Boyd, and Andrey Shaw. Furthermore, Dr. Gitlin will have access to coursework, retreats, seminars and
resources through Stanford University’s School of Medicine, The Stanford Office of Postdoctoral Affairs, and the
Genentech Postdoctoral Program. Finally, the scientific resources available to Dr. Gitlin comprise the
Pulendran/Dixit laboratories and core facilities at both Stanford University and Genentech, representing an
extraordinary set of scientific resources. The research proposal detailed herein seeks to uncover the molecular
mechanisms by which linear ubiquitin controls the magnitude of the innate immune response. Dysregulated
inflammatory and cytokine responses are fundamental features of multiple chronic diseases, including
autoimmunity, autoinflammatory syndromes, infectious diseases, immunodeficiencies and cancer. Yet, many of
the complex signaling pathways that regulate inflammatory signaling are still being unraveled at a mechanistic
level. During Dr. Gitlin’s short time as a co-mentee of Drs. Dixit and Pulendran, he has discovered that the
NEDD4-binding protein 1 (N4BP1), a linear ubiquitin-binding protein, is a novel regulator of toll-like receptor
(TLR) responses. In Aim 1, we will test the hypothesis that N4BP1 differentially regulates inflammatory cytokine
production downstream of TLR signaling. In Aim 2, we will dissect the mechanistic basis of N4BP1 activity by
inactivating its independent functional motifs. We anticipate these studies will elucidate a novel pathway by which
a previously enigmatic linear ubiquitin-binding protein selectively controls the cytokine output of TLRs. These
studies provide an excellent platform for Dr. Gitlin to complete his training and launch his independent career.

Public health relevance
PROJECT NARRATIVE Linear ubiquitination is an essential post-translational protein modification that controls immunity and inflammation, as evidenced by multiple immune-mediated diseases caused by mutations in genes encoding the linear ubiquitin chain assembly complex (LUBAC), linear deubiquitinases, linear ubiquitin-binding proteins, and protein substrates of linear ubiquitination. We have identified a novel mechanism by which a linear ubiquitin- binding protein, NEDD4-binding protein 1 (N4BP1), controls inflammatory cytokine production upon activation of the innate immune system. This research proposal seeks to uncover the mechanistic basis for this anti- inflammatory function of N4BP1, which has the potential to shed light on multiple inflammatory diseases and provide novel strategies for modulating inflammation for therapeutic purposes.